A COMPARISON OF ENDOCRINE FUNCTION AND CYTOLOGY OF PITUITARY TUMORS

Clinical features, hormone function, immunocytochemical findings and surgical results of patients with functioning pituitary tumors.